Mechanisms of Fungal Iron Regulation and Thiol Redox Metabolism

PROJECT SUMMARY
There are no changes to the Project Summary of the parent proposal.

Public health relevance
PROJECT NARRATIVE There are no changes to the Project Narrative of the parent proposal.